Planning and Evaluation

Planning and Evaluation supports the strategic planning of the Comprehensive Cancer Center of Wake Forest University (CCCWFU). Operations of the CCCWFU are entrusted to specific Boards and Committees, which serve as administrative

Public health relevance
The planning and evaluation component of our Center is the catalyst to enhance our cancer research and evaluate new opportunities. It is essential that we have our various internal and external committees and boards to ensure the trajectory of our scientific foci are delivering the highest quality scientific discoveries to enhance patient care, which is our ultimate goal.